FEASIBILITY OF EM CHARACTERIZATION FOR MEMBRANE PROTEIN CRYSTALLIZATION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This project is a feasibility study to investigate the utility of using EM screening methods to characterize the purification and crystallization stages for membrane proteins suitable for x-ray crystallography.